Molecular Structure Determination by Mass Spectrometry and Computational Modeling

PROJECT SUMMARY/ABSTRACT
Structural biology plays a central role in modern molecular bioscience, enabling both a greater
understanding and new mechanisms of manipulation of biomolecular action. However, despite tremendous
development in tools for the generation of high resolution molecular models, large families of biomolecules and
biomolecular complexes are still poorly represented in databases of protein structure due to limitations of
current technology, and methods for probing protein structure within mammalian tissue are few. One method
that has been used successfully to qualitatively study the structure of several of these families is hydroxyl
radical protein footprinting (HRPF), an emerging technology that has been used to study changes in protein
topography by measuring changes in the apparent rate of reaction between hydroxyl radicals generated in situ
and amino acid side chains on the protein surface. Our initial work has developed HRPF into a quantitative
measurement of protein topography at the individual amino acid level, accurately measuring the average
solvent accessible surface areas (<SASA>) of many individual amino acids in a single experiment. In this
renewal, we will expand our technology into structural systems that change dynamically with time, including
protein posttranslational modification systems, large heteromeric protein complexes, and protein:carbohydrate
complexes. The core technology we will develop to enable these studies is high performance liquid
chromatography coupled inline with amino acid resolution HRPF (LC-HR-HRPF). Inline liquid chromatography
allows the separation of protein conformers and immediate quantitative measurement of the purified
conformers’ topographies by HR-HRPF before the dynamic system has a chance to re-equilibrate, freezing the
structural information in the stable chemical footprint. We will also develop technology for analysis of protein
structure within mammalian whole blood, enabling the study of protein structure and interactions within highly
complex native systems. We will develop flow systems to precisely and carefully deliver hydrogen peroxide to
blood for protein labeling without damaging cells, and will demonstrate the technology with the structural
analysis of monoclonal antibodies dosed into a mouse model. Finally, we will develop technologies to probe
the topography of complex carbohydrates, enabling us to measure which parts of carbohydrates mediate
interactions with proteins, even in complex mixtures of glycans. We will develop both reducing-end specific and
non-specific labeling strategies for probing carbohydrate topography. Together, these advances represent
potential transforming technologies for the structural analysis of biomedically important and highly challenging
systems.

Public health relevance
PROJECT NARRATIVE Molecular models of biomolecular structures have led to a revolution in the way we understand and manipulate the molecules of life. However, due to limitations of current technology, large gaps remain in our understanding of the three-dimensional structure and dynamics of biomolecules and biomolecular complexes, including many critical to human health. Here, we propose to develop powerful and flexible technologies that allow researchers to measure biomolecular structures that change over time, as well as measure protein structures and complexes within mammalian whole blood.